Administrative Core

CORE A, Administrative Core Summary
The purpose of Core A (Administrative Core) is to provide administrative, fiscal, and information technology (IT)
support to all projects within the CCHI. The Core will be based at LJI, the CCHI’s home institution and will be
utilized equally by all projects. The Administrative Core provides a central focus for the program. The
Administrative Core of the CCHI will facilitate interactions between the projects and with the National Institutes
of Health. The goal of this core is to provide programmatic direction and promote interaction between the
investigators. It will be the responsibility of the Administrative Core to assure access to core facilities by all
Projects funded by this application.